Clinical Practice Network

PROJECT SUMMARY/ABSTRACT
The purpose of the Clinical Practice Network (CPN) of the MATCHES Telehealth Research Center is to
provide the environment for conducting and evaluating the Center’s investigations of telehealth-supported
cancer care. MSK’s New York City locations and six regional care sites will constitute the CPN. MSK is a high-
volume cancer center with a robust infrastructure for delivering telehealth via both synchronous and
asynchronous technologies. As such, the CPN also will serve as the Center’s practice innovation and digital
innovation hub for implementing and evaluating telehealth, as well as nimbly translating the generated
evidence back into clinical practice. The CPN will convene patients, clinicians, staff, and scientists to test and
refine equitable telehealth solutions, and novel computational and hybrid practice models, all based on
principles of user-centered design. The CPN’s specific aims are 1) to develop and equitably deploy enhanced
telehealth tools, 2) to develop and deploy MSK@Home telehealth-supported services in the context of the
Center’s Pragmatic Trial, 3) to identify and implement sustainable methods of patient and clinician engagement
to refine telehealth-enabled interventions, and 4) to test and refine novel computational, operational, and
staffing models for the delivery of telehealth-supported cancer care at home.
Led by Peter D. Stetson, MD, MA, with Co-Directors Diane Reidy-Lagunes, MD, and Gilad J. Kuperman, MD,
PhD, and support from a multidisciplinary leadership team from across MSK, the CPN will act as the effector
arm and feedback sensor for implementing the MSK@Home
intervention to be evaluated via our Pragmatic
Trial and will perform similar functions across the planned pilot studies.
It will orchestrate the deployment of
telehealth solutions across the study sites, as well as coordinate data collection and management for the study
interventions. The CPN team will establish and monitor the experience of patients, clinicians, and front-line
staff through regular review of key success metrics with the Administrative Core’s Patient Engagement Unit
and Clinician & Staff Engagement Unit. The CPN team will develop and deploy a novel, standardized common
data model for telehealth and patient-generated health data. They will extract, aggregate, and deliver
multimodal data insights from the telehealth platform and additional key systems for operational leadership in
the CPN to adjust to conditions on the ground, as well as for the data scientists in the Research & Methods
Core to develop new digital biomarkers and computational models. The CPN team will manage the process to
adjust implementation of the study interventions as a result of change in regulatory and financial requirements
and as cancer centers evolve best evidence in the use of telehealth. In collaboration with the Office of Diversity
Programs, the CPN will develop proactive monitoring tools, visualizations, and recovery mechanisms to ensure
telehealth technology reduces rather than exacerbates the digital divide and other barriers to high-quality
healthcare, with a particular focus on at-risk patients.